The Role of Home Care Cooperatives in Home Health Aide Turnover, Job Quality, and Care Quality

PROJECT SUMMARY
Geoffrey Gusoff, MD, MBA, MS is a clinician-researcher, family physician, and post-doctoral fellow in the
National Clinician Scholars Program at UCLA. Dr. Gusoff’s work integrates insights from business, clinical
care, and aging research and focuses on the impacts of participatory business models like home care
cooperatives on job quality, care quality, and access in long-term care. Severe workforce shortages and high
turnover rates among home health aides (HHAs) increasingly prevent older adults from accessing the care
they need to age in place. Studies suggest HHA shortages and turnover are largely driven by poor working
conditions, including irregular hours, low wages, and the exclusion of HHAs from workplace decisions (e.g.
patient care planning). In this landscape of high turnover and poor working conditions, home care cooperatives
– businesses designed to prioritize HHA participation in workplace decisions – have achieved higher wages,
greater patient retention, and half the turnover rates of other home care businesses according to industry data.
This data suggests the cooperative model may be associated with better worker retention, job quality, and care
quality, but empiric research is needed to investigate these potential associations and their underlying
mechanisms. This proposal will develop and deploy a survey to HHAs at cooperative and non-cooperative
home care agencies to measure the association between the cooperative model and HHA workforce outcomes
(turnover, job quality, and care quality) and evaluate potential mechanisms of that association. With the goal of
creating a marketable tool to improve the lives of HHAs and their patients across the US, the proposal will also
partner with home care cooperatives to design and pilot test a digital training product aimed at improving HHA
turnover, job quality, and care quality by deepening HHA workplace participation. To effectively complete the
proposed studies and lay the foundation for a successful career in long-term care research and entrepreneurial
innovation, Dr. Gusoff will complete needed training in survey design, geriatrics, and implementation science.
To fill critical gaps in his business training to date, he will also complete an “MBA 2.0” in cooperative
entrepreneurship, which will provide the practical skills needed to develop transformative, participatory
business models within the long-term care sector. To accomplish these research and training aims, Dr. Gusoff
will draw on a diverse mentorship team of national and international experts including Primary Research
Mentor Catherine Sarkisian (geriatrics and community partnerships), Entrepreneurial Mentor David Hammer
(Executive Director of ICA Group, the leading home care cooperative developer in the US), Ron Hays (survey
development and psychometric evaluation), Moira Inkelas (implementation science), Madeline Sterling (home
health aide workforce), and Debra Saliba (long-term care quality). This research, training, and mentorship will
provide Dr. Gusoff the skills, knowledge, and experience necessary to launch his career as an independent
investigator and national leader in long-term care workforce innovation.

Public health relevance
PROJECT NARRATIVE Millions of older adults rely on care from home health aides (HHAs) to safely age in place, but high turnover and severe workforce shortages among HHAs increasingly prevent older adults from obtaining the care they need. Given a substantial body of evidence showing greater participation in workplace decisions is a key driver of HHA job satisfaction and retention, this proposal uses a cross-sectional survey to examine the role of home care cooperatives – businesses designed to prioritize HHA workplace participation – in HHA turnover, job quality, and care quality, and also designs and pilot tests a scalable digital training product aimed at enhancing HHA workplace participation. The project will also provide critical training and mentorship for Geoffrey Gusoff, MD, MBA, MS, an early career investigator seeking to be a leader in long-term care workforce innovation.